Learning-Enabled Autonomous Decision-Support for Blood Pressure Management in Hemorrhage Resuscitation via Population-Informed Statistical Inference

PROJECT SUMMARY/ABSTRACT
Hemorrhage is accountable for approximately 40% of deaths due to traumatic injuries worldwide as well as the
leading cause of mortality in Americans 1-46 years of age. Since high rate of hemorrhage-induced deaths
occur before reaching definitive care, providing immediate life-saving interventions to hemorrhaging patients is
of paramount importance. Blood pressure (BP) management is a very important component of hemorrhage
resuscitation due to its central role in (i) reducing the hemorrhage-induced mortality as well as in (ii) developing
novel hemorrhage resuscitation protocols in clinical trials. But, clinicians are not effective at maintaining BP
within a goal range, and BP management protocol failures are common in clinical trials. Regardless, there is
no mature technology ready for clinical use to support clinicians with BP management.
By extending its ongoing success with an autonomous vasopressor administration guidance technology
currently undergoing a clinical trial under an FDA IDE, the investigative team proposes to develop a learning-
enabled autonomous decision-support (LEAD) system for BP management during hemorrhage resuscitation,
which can predict future BP in a patient and recommend timings and doses of resuscitation fluid administration
in order to maintain the patient’s BP within a clinician-specified goal range, while continuously optimizing its
accuracy by learning the patient’s response to administration of fluids. The LEAD system will be suitable for
clinical use in ICUs, EDs, and even pre-hospital environments. The LEAD system will be most impactful when
a clinician is novice, distracted, or tired. In addition, by maintaining clinicians in the loop, there will be much
reduced regulatory risk, allowing for rapid transition to a clinical trial and dissemination. In this way, the LEAD
system has the potential to enable tight BP management during hemorrhage resuscitation by enhancing the
awareness of clinicians on a patient’s dynamic treatment trajectory.
Key innovations pertaining to the LEAD system are (i) a novel population-informed, recursive, collective
statistical inference approach to prediction of future BP in a patient based on a physics-based physiological
model and a collective inference developed by the investigative team and (ii) its real-world implementation into
a computational user interface platform being ready for clinical use. To realize and validate the LEAD system,
we will (i) develop a BP prediction algorithm for the LEAD system via population-informed recursive collective
inference (SA1); (ii) evaluate the LEAD BP prediction algorithm using clinical datasets (SA2); and (iii) realize
the LEAD system using a computational user interface platform and conduct simulated real-time testing (SA3).
If this project is successful, the investigative team will proceed to technology commercialization and
translation by pursuing a follow-up R01 proposal to optimize the LEAD system algorithm and user interface
platform, and conduct a clinical trial under an FDA IDE.

Public health relevance
PROJECT NARRATIVE Hemorrhage is accountable for approximately 40% of deaths due to traumatic injuries worldwide as well as the leading cause of mortality in Americans 1-46 years of age. Blood pressure (BP) management is an important component of hemorrhage resuscitation due to its central role in (i) reducing the hemorrhage-induced mortality as well as in (ii) developing novel hemorrhage resuscitation protocols in clinical trials. We will develop a medical device system called the learning-enabled autonomous decision-support (LEAD) system, which can predict future BP in a patient and recommend timings and doses of resuscitation fluid administration in order to maintain the patient’s BP within a clinician-specified goal range, while continuously optimizing its accuracy by learning the patient’s response to administration of fluids.